Defining the roles of an enhancer long non-coding RNA eIncRNA-ID2 in rickettsial pathogenesis and immunity

PROJECT SUMMARY
Precise and dynamic alterations in gene expression are critical determinants of the regulation of host immunity
to microbial pathogens. Pathogenic rickettsiae in the spotted fever group cause some of the most severe
infectious diseases in humans, characterized by microvascular inflammation and dysfunction attributed to
disseminated infection of endothelial cells and increased vascular permeability resulting in pulmonary/cerebral
edema. Long non-coding (lnc) RNAs of ≥ 200 nucleotides regulate a panoply of biological responses through
an array of mechanisms and changes in their expression levels are now intricately linked to the determination
of innate as well as cell-mediated immune responses. As an important subset of lncRNAs, enhancer lncRNAs
implement their regulatory roles by enhancing protein coding genes (PCGs) in a cis- or trans-acting manner.
We performed RNA-sequencing on the lungs as one of the predominantly affected target organs of susceptible
mice infected with R. conorii to identify up-regulation of 179 lncRNAs. Via follow-up analysis to differentiate
enhancer (elnc) from promoter-associated (plnc) RNAs based on the ratio of single- versus tri-methylation of
histone 3 at lysine 4 (H3K4Me1:H3K4Me3) and other active enhancer signatures based on POLR2A, p300,
DNase I hypersensitivity sites, CTCF, and Hi-3C ChIP-Seq datasets, we further determined significantly higher
expression of an active elncRNA013718 and its target PCG Inhibitor of DNA binding 2 (ID2) in the mouse
lungs, spleen, and CD8+ T-cells during Rickettsia conorii infection. Our preliminary findings further suggest that
elncRNA013718 positively regulates the expression of ID2, a protein antagonist of E protein transcription
factors and a regulator of T cells in the immune system. Accordingly, we refer to elncRNA013718 as elncRNA-
ID2 and hypothesize novel contributory roles for elncRNA-ID2:Id2 interplay in the regulation of protective host
immunity during rickettsial infections. We propose to test this hypothesis via two independent yet thematically
interlinked specific aims. Aim 1 will distinguish cell type-specific expression and functional roles of elncRNA-
ID2 and ID2 in the host lungs and spleen in experimental murine models of R. conorii and R. australis infection.
In Aim 2, we will determine the modulatory effects of both global and cell-specific interference with elncRNA-
ID2 on host immune responses and disease progression/outcome. Given the complexity of cellular immune
responses, we will employ two independent and established in vivo models of infection closely mimicking the
pathophysiology of human rickettsioses and cutting-edge approaches of cellular microbiology and immunology
to determine the regulatory potential of elncRNA-ID2 as a novel elncRNA in the molecular circuitry underlying
regulation of host immunity. The acquired insights will enhance our knowledge of context-specific physiological
roles of elncRNA-ID2 in the determination of host responses to pathogenic rickettsiae and reveal potentially
unique entry points for novel strategies to enhance host immunity against intracellular microbial infections.

Public health relevance
PROJECT NARRATIVE Long non-coding (lnc) RNAs are emerging as important regulators of a range of host responses to infectious insults, including differentiation, maturation, migration, activation, and functions of a variety of immune cells. This application addresses the functional implications of elncRNA-ID2, a novel enhancer lncRNA element, in the context of mechanisms of pathogenesis and host immunity using murine models of tick-borne spotted fever rickettsioses. As a fundamentally important area of scientific enquiry at the crossroads of Cellular Microbiology, Immunology, and RNA Biology, definition of regulatory functions of novel lncRNAs will exert a sustained and potentially cross-disciplinary impact on their roles in inflammation and immunity during human diseases.